Translational Aging Research Training Program

The population of older adults with chronic disease states and functional and cognitive decline is growing
rapidly in the US. In parallel, there has been a rapid expansion in the understanding of aging-related biology
that may drive these changes, and a rapid expansion in the development of bioengineering and engineering
approaches that can be utilized to help solve health care-related issues. Despite this progress, there remains a
gap in the ability to translate biological understanding and engineered approaches into modalities that improve
the health and well-being of older adults. In order to further accelerate the pace of discovery in this space, The
Translational Aging Research Training Program was successfully implemented in 2018. Despite COVID-19
related disruptions, 14 fellows from clinical, engineering, and biological disciplines were trained to work in this
space during the first cycle. The Johns Hopkins Human Aging Project (HAP) has been intentionally designed
as a hub that provides interdisciplinary connections with focus on accelerating improvements in the healthspan
of older adults. This renewal application describes an updated training program that will take place within the
unique HAP ecosystem. The scientific leadership, the research infrastructure, and the diverse and inclusive
environment in this ecosystem will continue to provide an outstanding translational research training venue in
the next cycle. Specific aims include: 1) the implementation of a diverse, inclusive and rigorous interdisciplinary
training program in translational aging research for post-doctoral fellows with MD and PhD degrees through a
structured program consisting of a core series of required coursework, interdisciplinary scientific meetings,
weekly trainee focused translational aging seminars, individualized training programs, and leadership and
career development seminars; 2) the provision of trainees with a primary directed translational aging laboratory
experience (either engineering or biology focused) or clinically oriented research project in collaboration with
an experienced mentor with research resources; 3) the provision of trainees with access to the robust
interdisciplinary and translation-focused aging research infrastructure and collaborative research opportunities
available at Johns Hopkins, and 4) the preparation of the trainees for sustained academic careers through
individualized mentorship and by utilizing the leadership and career development resources that are available
at Johns Hopkins University. At the end of this training program, trainees will have broad interdisciplinary
knowledge of aging biology, engineering and bioengineering approaches to problem solving, and major clinical
issues facing older adults, a broad knowledge of translational science, and the tools necessary to start a
successful academic career. Further, the trainee will have learned career development and leadership skill
sets that will facilitate the future development of influential interdisciplinary translational aging careers and
research programs.

Public health relevance
The population of older adults in the United States is expanding rapidly as is the understanding of the aging biology and engineering. In order to better train scientists to improve the health of older adults, clinical, biological, and engineering disciplines need to be brought together to solve problems and improve health of older adults. The purpose of this training program is to train postdoctoral fellows in translational aging research so that they can go on to become scientists focused on improving the health of older adults.